Metabolic Mechanisms of Naphthalene Toxicity in Lung

Naphthalene (NA) is a ubiquitous and highly abundant pollutant found in vehicle exhaust, fossil fuels and
wildfire smoke. NA causes nasal and lung toxicity, including tumors, in rats and mice, respectively, and is a
possible human carcinogen. The mechanism of NA carcinogenicity, which may involve both genotoxic and non-
genotoxic events, is not clear and may involve several reactive NA metabolites. A prerequisite for NA toxicity is
bioactivation by cytochrome P450 (CYP) to form NA-epoxide (NAO) which can undergo further metabolism in
the lung and liver to 1,2-naphthoquinone (1,2-NQ). Both NAO and 1,2-NQ can react with DNA. We have recently
uncovered a significant contribution of liver-generated NA metabolites to acute lung toxicity in vivo; identified
several NQ-DNA adducts in the mouse lung, liver, and blood following NA exposure and in blood samples from
human firefighters and lung biopsy samples of lung cancer patients; and gained novel insights on the
toxicokinetics of various NA metabolites. These exciting findings led to the current proposal, to test the novel
hypothesis that liver-generated reactive NA metabolites are transported to the lung where they contribute to NA's
cytotoxicity, genotoxicity, and carcinogenesis. We are well positioned to address this hypothesis due to the
genetically modified mouse models we have developed, the recent methodologic advances we have made in
metabolite and DNA adduct characterization, and the exposure systems we have in place to expose mice acutely
and/or chronically to NA vapor at defined doses. A series of mechanistic and translational studies will be carried
out in four Specific Aims that will 1) identify key metabolic events that control NA DNA adduct formation in the
lung, 2) determine whether serum albumin facilitates transport of liver-generated reactive NA metabolites to the
lung, 3) identify whether key metabolic events in the liver mediate NA-induced lung tumorigenesis in vivo, and
4) characterize profiles of NA metabolites and DNA adducts in blood and urine from firefighters. Our long-term
goal is to identify metabolic mechanisms that benefit risk assessment for chemical-induced lung toxicity and
carcinogenesis in humans. The proposed studies remain focused on metabolic mechanisms underlying NA
respiratory toxicity and address mechanisms for the hepatic contribution to lung toxicity, link hepatic NA
metabolism to lung tumorigenesis, and examine biomarkers of NA's genotoxicity in humans. These studies
define key metabolic events that influence NA-mediated lung toxicity and carcinogenesis. Success of the
proposed studies will move the field of mechanistic toxicology forward toward a better understanding of fate and
importance of circulating reactive metabolites and shift the paradigm for NA risk assessment, by providing proof-
of-principle evidence for the importance of circulating (as well as locally generated) NA metabolites in NA's
genotoxicity and lung tumorigenesis, identifying accessible biomarkers for monitoring potential NA genotoxicity
in humans, and advancing the understanding of hepatic NA bioactivation as a risk factor that may predispose
individuals to NA-induced lung carcinogenesis.

Public health relevance
Naphthalene is a volatile polycyclic aromatic hydrocarbon to which humans are highly exposed as it is in the vapor phase of combustion of fossil fuels and wildfire smoke. Naphthalene is a possible human carcinogen but there is controversy on the mechanism of carcinogenicity in humans. The proposed studies will investigate the role of hepatic bioactivation of naphthalene and a genotoxic mode of action in naphthalene-induced lung toxicity and tumorigenesis, using novel analytical methods, transgenic mouse models, and naphthalene exposure systems in mechanistic studies and testing translational relevance of key findings using blood and urine samples from humans who have been exposed occupationally to naphthalene.